Targeting an atypical signaling hub to restore and protect whole body glucose homeostasis

Project Summary/Abstract – Type 2 diabetes (T2D) has now reached epidemic proportions worldwide. During
pre-diabetes, blood sugars rise and the risk of cardiovascular consequences, such as stroke, myocardial
infarction and mortality, is already increasing by 2-4-fold. Despite this, there remains a fundamental gap in
understanding how and why pre-diabetes develops. Strategies to halt or reverse T2D development require a
multi-pronged approach, since the pathophysiology involves both dysfunction in pancreatic β-cell glucose-
stimulated insulin release, and in skeletal muscle (skm) glucose uptake/clearance from the circulation. Factors
linked to failures in both processes are considered optimal therapeutic targets. We have identified the p21-
activated kinase, PAK1, as such a factor; it is a signaling hub in both the β-cells and skm that orchestrates
multiple aspects of glucose homeostasis. PAK1 is deficient in T2D, suggesting that its loss may be a “roadblock”
that prevents normal signaling in T2D. To overcome the roadblock of PAK1 deficiency, we need to understand
the mechanisms linking PAK1 to its functions in β-cells and skm. Our long-term goal is to understand how β-cell
and skm signaling can be manipulated to prevent or reverse pre-diabetes and halt the progression to T2D. Our
central hypothesis is that 1) signaling through the PAK1 hub in the β-cell controls functional β-cell mass to
reverse HFD-induced glucose intolerance, and that 2) PAK1 signals in skm confer protection from insulin
resistance and engage in tissue crosstalk to enhance β-cell function. The rationale for the proposed research is
that once these new mechanisms of the PAK1 effectors are elucidated, select signaling pathways from the PAK1
hub can be manipulated to prevent or reverse T2D. During the last funding cycle, we revealed that restoring
PAK1 in T2D human islet β-cells reverses dysfunctional insulin secretion while reducing β-cell mitochondrial
dysfunction and apoptosis. We also showed that PAK1 enrichment in skm protects against HFD-induced glucose
intolerance, and engages in tissue crosstalk to improve β-cell function. Our provocative new preliminary data
also indicate which PAK1 effectors carry out these essential functions. Therefore, the objective of this application
is to test these candidate mechanisms linking PAK1 effector enrichment and protection of β-cells and skm from
diabetogenic stress and to evaluate candidate PAK1 effector enrichment therapeutics. We will use our inducible
tissue-specific mouse models and human tissues/cells for these studies. In Aim 1, we will identify how the PAK1
effectors restore β-cell function; in Aim 2, we will elucidate the mechanism(s) by which PAK1-effectors protect
β-cell mass; in Aim 3, we will discern the mechanisms by which skm PAK1 contributes to peripheral insulin
sensitivity and β-cell health. We will use innovative molecular tools to test novel hypotheses about these PAK1
effector actions in the context of a translation-focused institutional environment at City of Hope. This work will
positively impact diabetes research by evaluating a promising candidate strategy to reverse pre-diabetes and
halt progression to T2D and by uncovering novel mechanisms of glucose homeostasis.

Public health relevance
Project narrative The research described in the current proposal is highly pertinent to public health because the discovery of factors that restore and/or prevent conversion to hyperglycemia will provide new therapeutic targets to ameliorate pre-diabetes. The current research proposal and the knowledge gained and mechanical details dissected fits the purview of NIDDK’s mission to reduce burden of diabetes.